The impact of increased mutation burden on promoting clonal hematopoiesis

PROJECT SUMMARY/ABSTRACT
Somatic mutations occur in hematopoietic stem cells (HSCs) throughout life. By chance, a mutation may disrupt
a key gene and confer a competitive advantage on the mutant HSC, leading to expansion of its clonal progeny.
This phenomenon is called clonal hematopoiesis (CH) and is ubiquitous with increasing age. CH is associated
with elevated risk for hematological malignancy, cardiovascular and pulmonary diseases, type II diabetes, and
overall all-cause mortality. Nearly all adults older than 50 years harbor CH clones with mutations in leukemia-
associated genes, but these mutant clones comprise a very low fraction of total blood cells and thus are
speculated to be functionally inert. A growing body of literature indicates that, in most individuals, low-frequency
mutant clonal blood fractions remain stable over time. However, no models exist that capture the behavior of
these stochastically arising low-frequency clones. Thus, whether driver mutation acquisition and adequate time
will lead to eventual clonal expansion remains unknown. The goal of this proposal is to determine the extent to
which underlying HSC mutation burden and acquisition of CH drivers are sufficient for clonal expansion over
time. Preliminary calculations predict every coding gene is mutated about 70 times in the HSC pool during an
average human lifespan, indicating mutation in a CH driver gene is inevitable with longevity. In contrast, native
CH has never been reported in murine models, possibly because mice have fewer HSCs and a limited lifespan
during which to acquire HSC mutations. The central hypothesis of this proposal is that clonal hematopoiesis
emergence is the product of sufficient mutation rate and time. I will evaluate this hypothesis using two murine
models for stochastic mutation acquisition. Experiments proposed in Aim 1 will query aged wild-type mice to
determine the extent that advanced age, independent of lifespan, promotes the development of CH. In Aim 2, I
will experimentally elevate the global mutation burden in murine HSCs to determine if the stochastic acquisition
of a CH driver mutation will lead to mutant clonal expansion over time, and how an aged milieu impacts CH
development. The experiments will define the sufficiency of mutation burden and time for promoting clonal
hematopoiesis and will determine the role of an aged microenvironment in clonal expansion. Overall, this work
may uncover strategies to enhance healthy aging via modulation of mutant clonal outgrowth.

Public health relevance
PROJECT NARRATIVE Nearly all adults after middle age display clonal hematopoiesis, a phenomenon in which mutated cells are overrepresented in the peripheral blood, increasing risk for hematological malignancy and cardiac disease. While low-frequency mutant clones are present in most adults by middle age, our understanding of the factors that promote eventual clonal expansion remains limited. The objective of this study is to determine whether mutant hematopoietic stem cells always expand with enough time and underlying mutation burden, with the ultimate goal of enhancing healthy aging.